Clearing the Fog: Characterization of the Phenotypic and Neurophysiological Features of Cognitive Dysfunction in Fibromyalgia

Project Summary
Pain in the United States is common and costly, with over 1 in 3 individuals being afflicted, causing an
economic burden approaching $600 billion annually. Fibromyalgia (FM) is characterized by widespread chronic
pain and co-morbid symptoms of psychological disturbance, and cognitive dysfunction. Cognitive symptoms
are particularly distressing and one of the most disabling aspects reported by patients. Neuroimaging
techniques, such as electroencephalogram (EEG) and functional magnetic resonance imaging (fMRI), have
identified central nervous system (CNS) mechanisms affecting the brain in these individuals, contributing to
their ongoing pain. Objective cognitive impairments and subjective complaints have been consistently identified
in FM; however, there remains a common discrepancy between subjective and objective findings in the
literature and there is scarce information as to the relationship with observed CNS mechanisms. Therefore, a
more comprehensive evaluation of this issue is needed. Furthermore, there remains a lack of sensitive clinical
biomarkers pertaining to the nature of cognitive complaints in FM, the development of which is a vital next step
towards effective interventions. To date, no study has systematically sought to understand cognitive
dysfunction in FM by combining neuropsychological assessments, patient-reported measures, and
neurophysiological (EEG) aspects. This empirical gap highlights a timely opportunity to understand and
address a potential avenue for thorough understanding, diagnosis, and treatment of cognitive symptoms in FM.
The proposed project and closely aligned training plan will fill this empirical gap by comparing subjective and
objective cognitive assessments between individuals with FM and healthy controls. We will also use EEG to
evaluate the neurophysiological features underlying cognitive dysfunction in FM and relationships with clinical
outcomes using a cognitive paradigm shown to be sensitive to preclinical cognitive impairments. We will build
from the robust framework of the Michigan Chronic Pain and Fatigue Research Center and an ongoing NCCIH-
funded R01 to the primary mentor, Dr. DaSilva, to recruit a well characterized study sample and add a
thorough examination of cognition. Specifically, we will use a cross-sectional design to assess subjective and
objective cognitive functioning as well as the influence of co-morbid symptoms in FM on the relationship
between objective and subjective elements (Aim 1). We will also utilize EEG to identify neural biomarkers of
cognitive dysfunction based on performance on a memory task (Aim 2). Finally, as an exploratory aim (Aim 3)
we will analyze fMRI data in a subset of the FM sample to evaluate the relationship between brain responses
to pain and cognitive symptoms. The proposed training in FM, application of statistics to self-report measures,
neuroimaging, and training in interventional approaches to guide future research (i.e., neuromodulation) will
create the ideal foundation for the candidate to excel as an independent researcher and become a leading
expert in the field, advancing our knowledge of cognitive symptoms in chronic pain conditions.

Public health relevance
Project Narrative The proposed project will characterize the phenotypic nature of cognitive dysfunction in fibromyalgia (FM) using a combination of self-report and objective measures of cognition, complemented by neurophysiological (EEG) and functional magnetic resonance (fMRI) outcomes. Cognitive symptoms are one of the most debilitating aspects of FM, are poorly understood and thus poorly managed, and are present in a wide range of chronic pain conditions beyond FM. Therefore, this project addresses a critical practical challenge that has applications for the improved healthcare management of a broad range of patients suffering from chronic pain.